Cooking skills to improve long-term weight loss in young adults with intellectual disabilities

ABSTRACT
Young adults with ID (age 18-26 yrs.) especially those with Down syndrome, are an underserved population
with a high prevalence of obesity (~45% by age 30), obesity related health conditions, and a reduced ability to
complete instrumental/basic activities of daily living (I/ADLs). Young adults with ID no longer have the daily
structure of attending public school with access to specialized medical services, may spend more time at home
or residential day centers, begin to live independent of their parents, or to work outside the home which may all
contribute to increased consumption of fast/processed higher calorie foods and decreased PA leading to
accelerated weight gain. Thus, interventions to address long-term weight loss may have a significant impact on
health in young adults with ID. Our research group has completed 2 NIH funded multi-component intervention
trials which have demonstrated clinically relevant short and long-term weight loss (18 mos.) in adults with mild-
to-moderate ID and overweight or obesity. However, we have been unable to achieve similar success for long-
term weight loss using these intervention strategies in young adults with ID. A position paper from the Academy
of Nutrition and Dietetics highlighted the importance of nutrition related services for individuals with ID across
the lifespan; however, evidence based nutritional services for this group are essentially non-existent. Limited,
data from other investigators and a pilot trial by our group, support the feasibility of delivering cooking skill
interventions to individuals with ID. However, there are no adequately powered trails that have evaluated the
effectiveness of a cooking skill intervention on long-term weight loss in young adults with ID. Thus, we propose
to evaluate the impact of a cooking skills intervention in combination with a multicomponent weight
management intervention on long-term weight loss (18 and 24 mos.) in 114 young adults with (50% with Down
syndrome) and overweight/obesity. Participants-parent/caregiver dyads will be randomized (1:1) to a traditional
weight loss (eSLD) or a weight loss plus cooking skills (eSLD+Chef-ID) arm for a 24-mo. trial (6 mos. loss/12
mos. maintenance/6 mos. no-contact follow-up). Our primary aim will compare weight loss across 18 mos.
between intervention arms. Secondary aims will compare weight change across 24 mos. and change in
cooking skills, body composition, cardiometabolic biomarkers, I/ADLs, and caregiver strain across 18 mos.
between intervention arms. Additionally, we will explore potential mediators/moderators of weight change
across 18 and 24 mos., and the association between changes in weight/body composition and cardiometabolic
biomarkers across 18 mos. If the proposed project is successful, entities providing weight management
services will have an evidence-based intervention for long-term weight loss for young adults with ID.

Public health relevance
PROJECT NARRATIVE Young adults with ID represent an underserved segment of the population with a high prevalence of obesity and a high risk of additional weight gain. However, there have been no successful interventions to achieve long-term (≥18 mos.) weight loss in this population. If the proposed project is successful, entities providing weight management to young adults with ID will have an evidence-based intervention for long-term weight loss to offer to their clients.